The influence of coevolutionary feedbacks on the origins and maintenance of genetic pleiotropy

PROJECT SUMMARY/ABSTRACT
Pleiotropy, where one gene affects multiple discrete traits, presents an interesting puzzle for evolutionary biologists
because mutations that are adaptive for one trait could antagonize the function of another. Recent studies in humans and
other organisms have suggested that pleiotropy is extremely common, raising fundamental questions about the function
and maintenance of pleiotropy over evolutionary time. There is a long-acknowledged but poorly studied observation that
many innate immune signaling pathways in plants, insects, and other taxa also play dual roles in modulating development
and other conserved traits. Several studies on genomic signatures of selection have pointed out that pleiotropy constrains
the rate of adaptation, which clashes with theoretical and empirical expectations that immune systems need to adapt
quickly to counter the rapid evolution of pathogens and parasites. As central questions in my lab evolve around the
evolution of immune systems, we want to investigate why pleiotropy is so broadly maintained in immune systems if it
could constrain adaptation.
My lab will employ several complementary approaches that account for feedbacks across biological scales to study the
impact of pleiotropy on host-parasite coevolution. In our first approach, we will integrate genomic data from insect and
vertebrate model organisms to investigate selection pressures acting on pleiotropic genes, transcripts, and protein domains
and define common features of pleiotropic signaling networks. At the same time, we will build computational models of
signaling network evolution to test whether single-sided evolution or coevolution against parasites fundamentally alters
the maintenance of pleiotropy in networks. Our third approach will employ experimental evolution to target the
deployment of pleiotropic signaling networks during the insect (Tribolium castaneum) host response to manipulative
parasites so that we can investigate whether pleiotropy alters coevolutionary outcomes at genotypic and phenotypic levels.
The molecular evolution results from the first approach will help us build more realistic networks for the agent-based
models, which will then provide salient hypotheses for the experimental evolution outcomes. In turn, the coevolution
experiments will provide empirical insight into statistical signatures of selection and model predictions from the first two
approaches.
Together, these research avenues will provide insight into an array of fundamental questions about the extent of genetic
pleiotropy among essential physiological processes, the influence of pleiotropy on coevolutionary dynamics, and the role
of immune system architecture in host adaptation to parasite pressure. Gaining greater insight into the evolutionary forces
that shape biological systems has important implications for predicting human pathogen evolution, understanding the
origins of diseases like autoimmunity and sepsis, and designing therapeutic treatments that minimize side effects.

Public health relevance
PROJECT NARRATIVE Innate immune genes are under natural selection to protect the host from pathogens, but emerging evidence suggests that at least some immune genes may also function in development, stress responses, and neuronal function, complicating our understanding of immune system evolution. We plan to uncover the extent of shared genetic architecture between innate immunity and other traits and determine its influence on the dynamics of host-parasite coevolution. Understanding evolutionary constraints on host-microbe interactions will improve predictions for pathogen evolution and ultimately shed light on the genetic basis of sepsis and other human diseases with complex genetic origins.